Enhancing diagnosis of Parkinson's disease and multiple system atrophy via detection of alpha-synuclein seeding activity

Synucleinopathies such as Parkinson's disease (PD) and multiple systems atrophy (MSA) involve abnormal
accumulation of the protein alpha-synuclein (α-syn). Although it has been nearly two centuries since PD was
first described, a dearth of biomarkers has greatly impeded progress toward development of disease-modifying
treatments and accurate and early diagnosis. This proposal is based on the hypothesis that pathology in these
diseases propagates through the brain via a mechanism in which transcellular movement of misfolded α-syn
protein aggregates or “seeds” occurs. There is also evidence that pathogenic α-syn has diverse structures in
diseases such as PD or MSA, that may underlie the clinical and pathologic differences seen in these
synucleinopathies. This proposal utilizes a novel cell-based assay that has been shown to detect and quantify
abnormal α-syn seeding activity that differs both biochemically and structurally in brain extracts from patients
with PD and MSA. In this project we propose to (1) optimize the ability to detect aggregated forms of α-syn
utilizing genetic manipulation of a cell-based sensor, (2) utilize cutting edge molecular and imaging techniques
to parse out differences between α-syn in the synucleinopathies MSA and PD, and (3) determine whether α-syn
seeding activity in blood components of patient samples can serve as a marker for clinical disease progression.
The implications of this work include facilitation of diagnosis and therapeutics for patients with PD and MSA.
The applicant is an Assistant Professor in the Department of Neurology at University of Kentucky, who is firmly
committed to an academic career as an independent translational scientist in the area of neurodegenerative
disease. The proposed training will take advantage of the rich and collaborative environment at the VA, the
excellent clinical documentation and records system, and the very relevant patient population affected by these
diseases and followed in clinic at the VA: all are factors that are integral and crucial to the success of this
proposal. Training will be conducted under the direction of an experienced mentor team. Dr. John Slevin, will be
the primary mentor, and has over 40 years of expertise in clinical research in Movement Disorders and holds a
Merit Award at the VA in basic science research. Dr. Sidney Whiteheart and Dr. Haining Zhu will serve as co-
mentors. They are experts in platelet biochemistry and abnormal protein aggregation, respectively, hold Merit
Awards in their fields, and are also faculty in the Department of Molecular and Cellular Biochemistry at University
of Kentucky. These mentors have been specially selected to advance the candidate’s knowledge of molecular
techniques for investigating aggregated proteins in peripheral fluids of patients with movement disorders.
Training during this proposal includes advanced genetic, molecular, and imaging-based techniques for protein
amplification and detection, and techniques for isolation and analysis of exosomal and platelet fractions from
whole blood. These components will be essential to completing the applicant’s immediate goal of developing a
biomarker that can detect and differentiate between synucleinopathies in peripheral samples by utilizing
differences in α-syn seeding activity. The comprehensive training program will position the applicant to conduct
independent research in the study of novel biomarkers in PD and related neurodegenerative disease.

Public health relevance
Parkinson’s disease is the most common neurodegenerative movement disorder of the elderly, affecting over four million people worldwide, and is responsible for significant health care dollar expenditures annually. This disease afflicts a disproportionately large number of US Veterans based on factors such as advancing age, male gender, and exposure to certain toxins, all of which are associated with increased risk for the disease. Progress toward effective treatment has been hindered by the lack of a biomarker that can diagnose and distinguish Parkinson’s disease from related neurodegenerative conditions. The proposed research will detect pathogenic forms of the protein alpha-synuclein in the blood of patients with Parkinson’s and related diseases, with the ultimate goal of expanding diagnostic, prognostic, and therapeutic options for affected US Veterans.